Bioanalytical, Cardiometabolic Phenotyping, Imaging and Histology Core

CORE B – BIOANALYTICAL, CARDIOMETABOLIC PHENOTYPING, IMAGING AND HISTOLOGY CORE
PROJECT SUMMARY/ABSTRACT
The Cardiorenal and Metabolic Diseases Research Center (CMDRC) was established to enhance research
infrastructure and provide mentoring to increase the ability of CMDRC investigators to successfully compete for
independent NIH funding. The Bioanalytical, Cardiometabolic Phenotyping, Imaging and Histology Sub-Cores
were established during Phases 1 and 2 to serve as a resource for the CMDRC, and Core B has had a
transformative effect on COBRE Junior Investigators and Pilot Grant investigators, and other users of Core B.
During Phase 1 and Phase 2 of COBRE support, Core B established consolidated, highly specialized services
and state-of-the-art resources critical to cardiorenal and metabolic diseases researchers; technologies and
services that would otherwise not be available to individual investigators. Core B is staffed by professional
personnel who are not only capable of performing a variety of essential research services, but are also able to
provide training and assist in the development of new research methods to meet the changing needs of COBRE
investigators. Core B has multiple components that include: the Bioanalytical Sub-Core that provides centralized
radioimmunoassay (RIA), ELISA, and other chemistry analyses; the Cardiometabolic Phenotyping Sub-Core that
provides centrally located, state-of-the-art, highly specialized in vivo phenotypical testing to characterize
physiological and behavioral parameters in genetic and pharmacological research models of obesity,
cardiovascular and metabolic disease; and the Imaging and Histology Sub-Cores that provide access to state-
of–the-art imaging equipment as well as histology, immunohistochemistry, and other key services. Over 88
investigators from 18 basic science and clinical departments at UMMC and 11 researchers from 8 other
institutions including Jackson State University, a Historically Black Colleges and Universities (HBCUs), used
Core B services and resources. Usage of Core B facilitated the generation of >260 publications and the funding
of 135 extramural grants from NIH and other non-profit funding agencies. Establishment of Core B as a Fee-for
Service Recharge Center initiated our Business Plan for our Model for Sustainability. The incorporation of
Centralized Billing and initiation of an Online Core Management System coupled to the commitment by UMMC
for continued support for capital maintenance and updates for capital equipment, and the significant increase in
independent extramural funding by users of Core B that established our Research Pool will ensure long-term
sustainability. Core B will continue to build upon our success so we can provide continuous support for existing
infrastructure and expand Core offerings.

Public health relevance
CORE B – BIOANALYTICAL, CARDIOMETABOLIC PHENOTYPING, IMAGING AND HISTOLOGY CORE PROJECT NARRATIVE The Bioanalytical, Cardiometabolic Phenotyping, Imaging and Histology Core B provides access to technologies and services that would otherwise not be available in Mississippi. The Bioanalytical Sub-Core provides centralized radioimmunoassay (RIA), ELISA, and chemistry analyses, the Cardiometabolic Phenotyping Sub- Core provides centrally located, state-of-the-art, highly specialized in vivo phenotypical testing to characterize physiological and behavioral parameters in genetic and pharmacological research models of obesity, cardiovascular and metabolic disease, and the Imaging and Histology Sub-Cores provide access to state-of– the-art imaging equipment as well as histology, immunohistochemistry, and other key services. This Core is staffed by professional personnel who are not only capable of performing a variety of essential research services, but are also able to provide training and assist in the development of new research methods to meet the changing needs of COBRE investigators.